Elucidating the contribution of microvascular remodeling to cervical softening during pregnancy with quantitative ultrasound

PROJECT SUMMARY
Despite efforts to improve medical practices, the rate of preterm birth in the United States continues to climb;
more than 1 in every 10 babies are born too soon. Many do not survive and those that do are susceptible to
lifelong health problems. Our inability to predict the time of delivery reflects our poor understanding of the
complex physiology of pregnancy and birth in general; while it is clear that the cervix softens, shortens and
dilates in preparation for birth, that microstructural changes underlie this process, and that premature changes
precede preterm delivery, precise information about how and why this remodeling occurs is lacking. As such,
non-invasive, in vivo methods are desperately needed to identify cervical remodeling in pregnant patients.
Cervical softening is a critical parameter to the clinician because it markedly accelerates near delivery (term
or preterm). Vascular changes are clearly fundamental to the remodeling of many tissues, but have never been
comprehensively explored in the cervix, in part because of technical limitations (resolution and sensitivity) of
previous imaging attempts. In this proposal, we leverage our expertise in statistical image reconstruction and
deep learning to develop a novel microvascular ultrasound imaging method with the potential to dramatically
improve the resolution and sensitivity by jointly minimizing errors in image reconstruction and the blurring effects
associated to the ultrasound beam size. We use this reconstruction approach, named Statistical icrovascular
Doppler, or S-Doppler, to shine light on the microvascular changes of the cervix during pregnancy.
Briefly, in aim 1 we optimize S-Doppler in calibrated phantoms to maximize resolution and contrast in
microvessel imaging. In aim 2, we validate in vivo the performance of the optimized technique to detect
microvascular remodeling in the gravid Sprague-Dawley rat, in which in vivo and ex vivo validation with Super-
Resolution Ultrasound (using microbubbles) and micro-Computed Tomography, respectively, are feasible. In aim
3, we demonstrate the translational potential of S-Doppler through a longitudinal study in pregnant Rhesus
macaques and investigate the contribution of microvasculature changes to cervical softening using an assay of
quantitative imaging biomarkers implemented on the same ultrasound probe.
The outcome of this proposal will be a novel, high resolution reconstruction approach to ultrasound
microvascular imaging without the need of microbubble-based contrast agents. Quantitative features extracted
from it will add to a growing toolkit of non-invasive in vivo imaging biomarkers for defining a personalized
ultrasound “fingerprint” of cervical remodeling, either at term or preterm. Ultimately, such tools will facilitate a
comprehensive understanding of specific cervical microstructural changes in a particular person’s pregnancy,
leading to accurate screening and tailored interventions that will help reduce the number of preterm births.
1

Public health relevance
PROJECT NARRATIVE (HEALTHCARE RELEVANCE) Obstetrical practice today is anchored in practices introduced a century ago because we know little more now than we did then about the complex physiology of pregnancy and birth. This proposal seeks to develop new imaging biomarkers based on in vivo microvascular ultrasound imaging to elucidate the role of vascular changes in the cervix as it softens in preparation for birth. Quantitative biomarkers to describe this process will be fundamental to a kit of tools to identify and address preterm birth, ultimately leading to tailored interventions based on a patient-specific biomarker “fingerprint” of pregnancy.